Macrophage Polarization and Function in GVHD

PROJECT SUMMARY / ABSTRACT
Graft versus host disease (GVHD) remains the major complication of allogeneic hematopoietic stem cell
transplantation (HSCT) and occurs following activation and expansion of alloreactive T cells. Among the tissues
and organs impacted by GVHD, the gastrointestinal (GI) tract is a critical and frequently involved locus of
disease. Clinically, GVHD damages the gastrointestinal (GI) tract in up to 60% of transplant patients, and the
presence of GI GVHD often exacerbates GVHD in other target organs. Improved strategies to eliminate GVHD
or decrease its severity are needed. Within the GI tract, macrophages are a tissue-resident innate immune cell
population that are derived from donor monocytes and possess plasticity between proinflammatory and anti-
inflammatory phenotypes. Macrophage survival and proliferation is largely regulated by signaling through the
colony stimulating factor 1 receptor (CSF-1R), of which M-CSF and interleukin-34 (IL-34) are the known ligands.
In preliminary data, we have shown that the absence of host IL-34 results in significantly impaired GI
epithelial barriers and exacerbated GVHD lethality. Mechanistically, the absence of host IL-34 led to skewing of
donor macrophages towards an inflammatory phenotype. Our lab further identified that the protection conferred
by IL-34 was contingent on apolipoprotein E (ApoE) production by donor macrophages. Based on these
preliminary findings, I hypothesize that IL-34 functions as a cytokine rheostat that skews macrophage
polarization towards an anti-inflammatory phenotype and thereby prevents pathological damage within the GI
tract during GVHD. In this proposal, I have outlined an approach to define the regulation of IL-34 production in
intestinal epithelial cells in GI GVHD, delineate mechanisms by which IL-34 inhibits the emergence of
proinflammatory T cells within the colon in GVHD, and define the role of ApoE in IL-34 mediated regulation of
GI GVHD.
I am firmly committed to an independent academic research career and am strongly supported in my career
development and research goals by my mentor, advisors, and the Department of Pediatrics at the Medical College
of Wisconsin (MCW). Institutional support includes 75% protected time for research, dedicated wet-lab bench
space, independent office space, and start-up funding for equipment and supplies. Under the guidance of my
primary mentor, William Drobyski, MD, and advisors Xue-Zhong Yu, MD, MS, MBA, Chien-Wei Lin, PhD,
Bonnie Dittel, PhD, and Joy Lincoln, PhD, I will advance my skills in cutting-edge single cell analytics techniques
and applied bioinformatics with direct application to the specific aims of this proposal. Completion of my
comprehensive training plan will provide me with the skills and experience necessary to become a successful
independent investigator with expertise in a novel IL-34, macrophage, and T cell signaling axis that influences
allogeneic immune responses in the GI tract during GVHD.

Public health relevance
PROJECT NARRATIVE While allogeneic hematopoietic stem cell transplantation (HSCT) is the only treatment with curative potential for many high-risk malignancies, its success rate is limited by the occurrence of graft versus host disease (GVHD). This project aims to dissect how interleukin 34 (IL-34), a cytokine produced by intestinal epithelial cells following HSCT, influences macrophage polarization, T cell function, and GVHD severity in the gastrointestinal (GI) tract. If successful, the proposed work will provide a rationale for the development of clinical strategies designed to reduce the severity of GI GVHD.